Substance Abuse Intervention Outcome Research Training

Project Summary
The aim of our multidisciplinary program is to train post-doctoral biomedical, behavioral, health care and other
public health scientists to conduct substance abuse intervention research. An overarching goal is to enhance
the scientific reasoning skills needed to advance treatment research in drug abuse. From our perspective such
research will benefit from interventions guided by sophisticated and fully-developed theory using a
multidisciplinary framework that includes the biological, psychological, social, cultural, and policy context in
which interventions occur. While other institutional training programs may address intervention research, this is
the primary mission for this program. Distinctive features of our training program are: that it is interdisciplinary;
that it embraces no single ideology or theory concerning the nature of dysfunctions related to drug abuse; that
it provides training in early intervention and treatment along a continuum; and that it provides trainees with
highly individualized opportunities to develop competitive grant applications and by doing so, contribute to the
knowledge base of substance-related dysfunction and treatment.
The training experience is structured to provide individualized research experience and training, complemented
by a core academic curriculum to which 20% of fellows' training time is allocated. Four distinct areas are
covered in the curriculum: (1) statistics/research methodology; (2) grantsmanship; (3) ethical issues in
research; and (4) a two-year series of formal courses covering the etiology and treatment of substance abuse
from varying disciplinary perspectives. We also subscribe to a research apprenticeship model under the
guidance of the research mentor. Each fellow's individual research training experience emerges from an
individualized development plan (“training plan”) developed by the fellow, agreed to by his/her mentors, and
reviewed and approved by the Training Committee. The program has a primary emphasis on training in
innovative treatment development and clinical trials research with a secondary emphasis on the translation of
clinical research into services research. Our research in behavioral economics, neuroscience, and behavioral
genetics expands our focus of translational research from basic to clinical. An additional area of emerging
prominence in our training program is tobacco regulatory science.
The expected training program duration is two years but on occasion we offer 3rd years of training, for example
for fellows with less extensive training in research methods; fellows who are cross-training, e.g. training in
Behavioral Genetics for a clinical psychologist; or for fellows in each cohort who need more time to accomplish
their goals of becoming independent investigators. The program accepts on average two new fellows per year.
At any given time there are likely to be four fellows in residence.

Public health relevance
Narrative This training program is designed to address the significant and costly public health problem of substance abuse by training postdoctoral biomedical, biobehavioral, health care, and other public health scientists to conduct substance abuse intervention research. Our training program draws on many scientific disciplines, including biological sciences, epidemiology and etiology, prevention, clinical, and public health research, and emphasizes multidisciplinary approaches to achieving innovations in substance abuse research. Cutting-edge training of the next generation of addiction researchers has the potential to accelerate the pace of science in the field of substance abuse research and treatment.